A Pilot Trial of High-Intensity Exercise to Combat Vascular and Cognitive Dysfunction in Older Adults with HIV.

PROJECT SUMMARY/ABSTRACT
This K01 Mentored Research Scientist Career Development Award will facilitate Dr. Jones’ long-term career
goal of conducting translational research focusing on the vascular contribution to cognitive aging in vulnerable
populations, namely individuals living with HIV who are at risk of cardiovascular disease and neurocognitive
impairment, and the benefits of exercise interventions. As age and HIV have independent and synergistic
effects on the brain, it places older people living with HIV (OPWH) at an increased risk of HIV-associated
neurocognitive disorder and Alzheimer’s disease and related dementias. Accelerated vascular aging, assessed
via arterial stiffness, is likely linked to those neurocognitive changes and exercise may be an effective,
nonpharmacological strategy to counterbalance the adverse vascular effects contributing to neurocognitive
disorders. The candidate is an exercise physiologist with a strong background in research on aging and
vascular health and function. The proposed research and career development plan builds directly on my prior
experiences to assess vascular health and function in aging, vulnerable populations. In line with the NIA’s
Strategic Directions of developing effective interventions to reduce the burden of age-related conditions, the
proposed pilot/feasibility study will explore the impact of high-intensity exercise on arterial stiffness and
cognitive functioning among OPWH who have neurocognitive disorders, and refine and finalize elements
critical to conducting future, fully powered randomized controlled trials (RCTs). Specific Aim 1 will evaluate the
feasibility (i.e., safety, adherence, retention) and preliminary impact of 12 weeks of high-intensity exercise
compared with continuous moderate exercise on arterial stiffness and cognition. Specific Aim 2 will be guided
by the Theoretical Domains Framework to qualitatively assess the baseline barriers to engagement in exercise
and the participant experiences of the exercise intervention. This award will enhance Dr. Jones’ career
development to conduct future, large-scale RCTs by 1) enhancing his proficiency in HIV and HIV-comorbidity
research, 2) developing expertise in HIV-associated neurocognitive impairment and assessment, 3) advancing
knowledge of exercise clinical trial development and implementation, and 4) attaining skills in qualitative
research methods to understand barriers to engagement and participant experiences. Dr. Jones’ mentorship
team is well-suited to facilitate the research and career development plan, with combined expertise in HIV,
cognition, exercise clinical trials, and qualitative methodology.

Public health relevance
PROJECT NARRATIVE Due to its prevalence and synergistic, deleterious effects on overall health and quality of life, arterial stiffness and neurocognitive disorders are public health concerns in older adults living with HIV. Therefore, this proposal is relevant to public health because it seeks to determine the vascular contributions to cognition and the preliminary impact of exercise, which is in accordance with the NIA Strategic Directions for Research as it addresses the development of “effective interventions to maintain health, well-being, and function to prevent or reduce the burden of age-related diseases, disorders, and disabilities.” This project will inform targeted interventions aimed at reducing the public health burden of arterial stiffness and neurocognitive disorders to promote healthy aging with HIV, which is responsive to the NIH’s HIV Research Priorities to reduce HIV- associated comorbidities and coinfections.